Investigating the Thalamic Regulation of Neuro-Glio-Vascular Restoration Underlying Acute Coma Recovery with Multi-Modal fMRI in a Brainstem Coma Rodent Model

Among millions of comatose cases per year, brainstem injury-induced coma shows a high death rate and a high
chance for patients remaining in a permanent vegetative state. For those who recovered consciousness, the
longer patients remain in a coma the poorer outcomes of their recovery. How to promote acute coma recovery
in a serious unmet need. Yet, although neuro-glio-vascular (NGV) restoration is crucial for acute coma recovery,
detailed NGV signaling, e.g. astrocytic function, and circuit-based mechanisms underlying NGV restoration have
not been thoroughly investigated in comatose patients due to inherent technical difficulties. We have recently
developed a brainstem coma rat model, providing an unprecedented opportunity to enable mechanistic studies
of coma recovery within an acute 12 hour time window, during which novel therapeutic interventions are of
translational interest to patients with brainstem injuries. Our goal here is to elucidate the mechanistic regulation
of NGV restoration underlying acute coma recovery. We will target the thalamocortical circuit with optogenetic
tools to elucidate circuit-specific mechanisms underlying NGV restoration during acute coma recovery. To study
NGV restoration, we will combine functional MRI with multi-channel fiber photometry-based Calcium (Ca2+) and
glutamate (Glu) recordings. This multi-modal fMRI platform reveals that central thalamic activation is coupled
with Intrinsic Astrocytic Ca2+ (IAC) transients during arousal fluctuation. This novel observation leads us to test
a central hypothesis that the thalamic regulation of IAC-specific NGV restoration underlies the acute coma re-
covery. Three specific aims will be assessed: 1). To test the hypothesis that arousal-related NGV signaling is
associated with acute coma recovery. 2). To test the hypothesis that thalamic stimulation promotes acute coma
recovery via IAC-specific NGV signaling. 3). To test the hypothesis that Glu-astrocyte signaling underlies the
thalamic regulation of IAC-specific NGV restoration during acute coma recovery. We hope that the first glimpse
of IAC-specific NGV restoration will help refine the therapeutic paradigm to target astrocyte function to promote
acute coma recovery. Our proposal is a timely convergence of novel brainstem coma rat model, advanced multi-
modal imaging technologies, and growing insights of NGV signaling, opening an unprecedented window into
investigating circuit-based mechanisms that underlie NGV restoration in acute coma recovery.

Public health relevance
Our goal here is to elucidate the mechanistic regulation of neuro-glio-vascular (NGV) restoration underlying acute coma recovery and to test a targeted pharmacological therapy that promotes NGV restoration in our novel, recently developed rodent model of brainstem coma. We hope that the first glimpse of thalamic regulation of astrocyte function and pharmacological modulation of glutamate- astrocytic signaling will help refine the therapeutic paradigm to target astrocytes to promote acute coma recovery.